CCR Collaborative Bioinformatics Resource

The CCR Collaborative Bioinformatics Resource (CCBR) is an organizational umbrella which provides a mechanism for CCR researchers to obtain many different types of bioinformatics assistance to further their research goals. This entity pulls together many different bioinformatics expertise within NCI, with strengths in a broad range of bioinformatics topics. The CCBR currently is providing support to over 80 Principal Investigators within CCR and are working on 120 projects related to several different general areas, including support to a wide variety of cancer genomics areas. The newest efforts have been in the area of single-cell genomics. Examples of collaborations leading to high-end publications include: 1) Regulatory relationships between CLIC4 and miR-142-3p in head and neck squamous cell cancers (Yuspa); 2) The first complete knockout of viral ORF57 gene from all copies of KSHV genome in BCBL-1 cells (Zheng); 3) Demonstration of the differences in methylation between metastases and primary tumors, demonstrating the effect of DNMT3B in epigenetic modifications allowing cancer cells to colonize different tissues (Yang); 4) The transcriptomic data of liver cancer used to identify four unique patient clusters, which were found to have different survival outcomes (Wang); and 5) Primary and secondary analyses of the exome-seq data, as well as integrative visualizations, including somatic mutations, germline ancestry, and mutational signatures analyses to demonstrate health disparities in cancer among minority populations (Ryan).